Cucurbit[n]uril-Type Molecular Containers

Project Summary / Abstract. The PI is Professor at the University of Maryland College Park since 1998 where
he runs a lab focusing on the design and synthesis of new cucurbit[n]uril-type molecular container compounds,
determination and understanding of the fundamental molecular recognition properties toward cationic guest
compounds including drugs and toxic substances in water, and demonstration of the use of these compounds in
important biomedical applications via key collaborations. The pioneering and impactful research contributions
of Dr. Isaacs and his group have been documented in 189 articles in peer reviewed journals which have received
over 15500 citations and garnered Dr. Isaacs election as fellow of AAAS and the 2018 ACS Chemical Society of
Washington Hillebrand Prize. Dr. Isaacs’s lab is/has trained 19 PhD, 21 postdocs, 12 MS, 41 undergrad, and 2
high school students. The vast majority pursued scientific research careers including 7 University faculty who
have launched successful independent academic research groups. The PI’s service record confirms a
commitment to graduate education (Director of chemistry graduate program and UMD GAANN fellowship
program), community building via leadership positions in the international supramolecular and CB[n] conference
series, scientific review for numerous journals and NSF and NIH panels, and junior faculty mentoring.
The vision of the research program is based on the realization that the lingering effects / presence of
biologically active substances (e.g. prescription and illicit drugs, (environmental) toxins) can lead to adverse
biological events, disease, and death. Common mitigation strategies include the pharmacodynamic medicinal
chemistry approach based on small molecule inhibitors and pharmacokinetic decoy protein / antibody based
sequestration approaches. CB[n]-type receptors exhibit tight aq. binding toward a variety of biologically active
compounds which renders them the prime supramolecular platform for systematic development as in vivo
sequestrants. Over the next five years we will master the synthesis of complex (acyclic) CB[n] receptors and
delineate their structure–binding affinity/selectivity relationships toward chemically and biologically active
compounds to advance supramolecular design principles for high affinity hosts suitable as in vivo sequestrants,
(targeted) delivery agents, and components of sensing ensembles. Structural variables to be probed include the
nature of glycoluril oligomer / building blocks, aromatic walls, and solubility determining groups. A key aspect of
meeting this goal is the implementation of an experimental-computational feedback loop via close interactions
with our collaborators. In addition, our participation in the SAMPL computational chemistry challenges by
supplying blinded (acyclic) CB[n] binding constant datasets will synergistically advance methods for aqueous
binding free energies calculations.

Public health relevance
Project Narrative: The premise of this project is that acyclic CB[n] – with their high binding affinity, straightforward synthesis, and outstanding biocompatibility – are ideally suited for development as in vivo sequestration agents for toxic substances from the gut and the bloodstream, as (targeted) drug delivery agents, as components of sensing ensembles, and as model systems for the SAMPL challenges. We propose to systematically vary the structural features of acyclic CB[n]-type receptors, study their molecular recognition properties in buffered water toward selected drugs / toxic substances, and engage with chemical and biological collaborators to demonstrate their utility in biomedical applications.